Community Outreach and Engagement

The long-term goal of UWCCC Community Outreach and Engagement activities is to decrease cancer
incidence and mortality among populations within our catchment area and beyond, including our
minority and underserved populations. We will achieve this goal through partnerships with other
health delivery systems and state and community agencies for dissemination of evidence-based
findings. Our specific aims are: (1) to understand our catchment area population through improved
data collection and analysis, with a special emphasis on identifying disparities, (2) to engage our
catchment area and state in clinical trials that are relevant to and appropriate for our
populations, including underserved populations, and (3) to work with and serve our community
organizations, affiliated health systems, and regional networks in the dissemination and
implementation of evidence-based interventions and health policy recommendations, particularly
for underserved populations. To accomplish these aims, the UWCCC engages researchers to build the
evidence base for interventions to benefit our catchment area and beyond, as well as integrate what
we learn from our catchment area into future research. Our UWCCC engagement activities and
scientific programs have focused on areas of significant cancer burden within our 36- county
catchment, including lung, breast, colorectal, and prostate cancer. Focus areas include lung and
breast cancer among African Americans, cervical cancer among Hispanics, lung and colorectal cancer
among American Indians, and delays in diagnosis among our rural residents. Colonoscopy screening
rates are low and smoking rates are high among low income residents, while alcohol consumption is
high. Through leveraging our extensive networks for research and outreach, we will engage our
catchment area residents in clinical trials and the broad- based activities that have been
shown to improve the health of, and in particular for, our disadvantaged populations. We
specifically expand engagement of our catchment area participants in clinical trials facilitated
through the National Clinical Trials Network, the Veterans Administration Hospitals and Clinics,
the Precision Medicine Molecular Tumor Board, and the UW Center for Tobacco Research and
Intervention. Disparities in clinical trial recruitment will be targeted by assessing and
addressing barriers to clinical trials participation, improving recruitment materials, and
developing targeted and culturally appropriate outreach. Our broad-based outreach activities
include dissemination and implementation of evidence-based interventions and health policy
recommendations for tobacco cessation, HPV vaccine uptake, colorectal cancer screening, and alcohol
use. We will also continue to expand our Cancer Clear and Simple curriculum developed
specifically for rural areas. Overall, we expect that these activities will continue to have a
substantial positive impact on reducing the burden of cancer within our catchment area.